Mississippi INBRE

MISSISSIPPI INBRE
OVERALL
Project Summary/Abstract
The Mississippi IDeA Network of Biomedical Research Excellence (MS INBRE) is a statewide network
dedicated to enhancing the biomedical research infrastructure among all higher education institutions in MS.
The overall goal of the network is to address health disparities and inequities by improving leadership and
knowledge concerning biomedical research and to increase awareness of health disparities prevalent in MS.
With this goal in mind, MS INBRE has developed its activities around three scientific themes that are major
impacts on Mississippians: cancer, infectious diseases, and obesity. MS is ranked third lowest in the United
States in terms of access to healthcare, primarily owing to the state's poor economy and historically low
investment in health care infrastructure. MS's biomedical research infrastructure has lagged in comparison to
other states, which creates a vicious cycle in which it is more difficult to make improvements in health care
equality and availability. MS is improving its health care and biomedical research infrastructure to improve the
health of the population. MS INBRE has played a key role in improving the biomedical infrastructure at partner
institutions and in educating and training underserved communities that have historically suffered from severe
health disparities. We have developed the following aims to carry out the overall goal of MS INBRE: 1)
Enhance the biomedical research capacity in Mississippi; 2) Develop a skilled and diverse workforce in
biomedical research and health-related careers; and 3) Engage underserved communities in Mississippi and
address health disparities. At the completion of the proposed project, we will augment the competitiveness of
Mississippi in biomedical research by improving the biomedical infrastructure at undergraduate institutions and
training of students.

Public health relevance
MISSISSIPPI INBRE Project Narrative The Mississippi INBRE network is designed to improve biomedical research in the state. This will be accomplished by 1) establishing research programs in Mississippi that focus on cancer, infectious diseases, and obesity, 2) by training students in biomedical research and increasing diversity in the research workforce, and 3) by engaging underserved communities to address health disparities.